CANCER CENTER SUPPORT GRANT

OVERALL - ABSTRACT
The Karmanos Cancer Institute (KCI), founded in 1943, is a not-for-profit, cancer-only research and patient
care organization in partnership with Wayne State University (WSU) in Michigan. The designation by the NCI
as a Comprehensive Cancer Center was achieved in 1978. KCI operates its wholly-owned, free-standing,
cancer hospital and ambulatory clinics (KCC) in Detroit and in Farmington Hills, a suburban location. As a
member of McLaren Health Care (MHC), a not-for profit health care corporation, KCI is also responsible for
cancer research, quality of care, and cancer care operations in all facilities owned and operated by MHC. Our
catchment area covers 46 of Michigan’s 83 counties with a population of 6.7 million people. This catchment
area is home to 95% of our patients, and KCI sees one-third of all new cancer patients in the catchment area.
The Southeast region of our catchment area includes the metropolitan Detroit, defined as a tri-county area
(Wayne, Oakland, Macomb) and home to 3.86 million residents. The city of Detroit is the largest city in the
state (672,000 residents). Detroit is a resource-challenged area, with a median household income of $27,838
and 37.9% of residents living below poverty level, compared to 16.7% in the state of Michigan. The majority of
census tracts in the city of Detroit are medically underserved areas based on HRSA definitions. About 79% of
Detroit residents identify as African American, a group that disproportionately carries KCI catchment area’s
cancer burden.
In 2018, KCI physicians saw approximately 12,000 new cancer patients (including approximately 8,000 analytic
cases), with approximately 15% representing minority groups. The annual number of new cancer cases in
these 46 counties is approximately 39,000 and has not changed significantly since 2014. In FY19, our minority
accrual to interventional treatment protocols was 24.2%. We have a long standing scientific and patient care
commitment to the African American population of southeastern Michigan, as exemplified in the broad array of
studies focused on molecular, therapeutic, and social disparities. This application profiles the strengths and
successes of our four scientific Programs, Tumor Biology and Microenvironment (TBM, 01), Molecular
Imaging (MI, 02), Molecular Therapeutics (MT, 03), and Population Studies and Disparities Research
(PSDR, 04). The research efforts of these Programs is supported by nine Shared Resources (Cores),
including one developing Core. As of December 2019, KCI’s 135 scientific members have secured total
annual direct project funding of $ 63,162,159 (an increase of 12.3% from 2015) of which $21,864,688 is peer
reviewed funding and $11,743,830 is from the NCI.

Public health relevance
OVERALL - PROJECT NARRATIVE In 2020, there will be an estimated 1.8 million new cancer cases diagnosed and 606,520 cancer deaths in the United States (source: American Cancer Society). The Karmanos Cancer Institute is a not-for-profit, cancer- only research and patient care organization whose mission is to be a transformative leader in cancer care, research, and education through courage, commitment and compassion. Key to achieving this mission is KCI’s research effort, which is conducted among four transdisciplinary Programs, organized to integrate basic, translational, and clinical research with population research-based cancer control activities.